Multi-parametric Integrated Molecular Detection of SARS-CoV-2 from Biofluids by Adapting Single Extracellular Vesicle Characterization Technologies

Abstract
The World Health Organization has recognized a global pandemic of novel coronavirus pneumonia (COVID-19)
from exposure to the severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2). Coronaviruses (CoVs)
are membrane-enveloped positive-sense, single-stranded RNA viruses decorated with membrane proteins. The
spike (S) glycoprotein is implicated in the viral attachment and fusion to host cells via the human angiotensin-
converting enzyme 2 (hACE2). There are different assays to test for COVID-19, including nucleic acid, antigen,
and serological tests that can be used in hospitals, point-of-care, and large-scale population testing. Nucleic acid
testing is the standard method for the detection of SARS-CoV-2, which consists of the amplification of viral RNA
from nasopharyngeal swabs (NPS) by quantitative reverse-transcription polymerase chain reaction (qRT-PCR).
Furthermore, given the invasive nature of NPS, saliva is being considered an alternative for detection. Methods
that bypass RNA extraction, as well as isothermal amplification such as loop-mediated isothermal amplification
(LAMP), have been developed to improve the speed of viral RNA detection. However, viral protein expression
cannot be detected by qRT-PCR. Serological tests, on the other hand, are based on host antibodies against the
virus (IgG/IgM). Although fast, these tests suffer from significant false negative/positive. Besides, they do not
detect a current infection. Therefore, to relieve the current healthcare crisis, new technologies capable of
simultaneous viral RNA/protein detection at the single virus level and host antibody response detection from a
body fluid in an integrated device would be highly valuable for enhanced COVID-19 diagnosis.
Recently, our group, as part of Phase 2 of the Extracellular RNA Communication Consortium (ERCC2), has
successfully developed a microfluidics technology capable of capturing individual exosomes from biofluids and
then simultaneously quantify both exosomal surface proteins and RNA cargo. Given the resemblance in size
and other characteristics between exosomes and coronaviruses, our technology can be adapted for COVID-19
diagnosis. Therefore, we propose to develop and validate a safe-to-use version of our microfluidics system for
direct detection of SARS-CoV-2. The integrated system is capable of multi-parametric detection for enhanced
COVID-19 diagnosis. The platform will be engineered to simultaneously quantify both viral protein, viral RNA,
and host antibodies (IgG/IgM) in the same sample, enabling diagnosis, disease status, and prognostic
assessment. Model systems, including host IgG/IgM from patient serum, standard synthetic vesicles (SVs), and
heat-inactivated SARS-CoV-2 viral particles (SVVs), will be designed and spiked in biofluids to validate and
calibrate the system. To demonstrate the clinical utility, our biochip technology will be deployed and tested using
different biofluids from COVID-19 patients at two independent laboratories (Institute of Systems Biology in
Seattle and The Ohio State University (OSU) Wexner Medical Center in Columbus). Measurements obtained
from the biochips will be compared to standard qRT-PCR and ELISA methods. A transition plan will be prepared
for FDA Emergency Use Authorization (EUA) application of the biochip technology through a COVID-19 clinical
testing laboratory at OSU Wexner Medical Center. A commercialization plan will also be developed via licensing
to a biotech company.
We have assembled a multi-disciplinary team with extensive knowledge and experience in nanobiotechnology,
microfluidics, micro/nano-fabrication, infectious diseases, and clinical COVID-19 patient sample collection and
testing. The proposed aims and milestones are given as follows:
Specific Aim 1: Development of an integrated biochip to simultaneously capture, fix, and characterize
single SARS-CoV-2 and IgG/IgM proteins. Milestones. (i) Sorting, capture, and quantitative analysis of
selected proteins and viral RNA in single virus in spike experiments with >95% repeatability; (ii) A sensitivity of
single virus detection with >90% repeatability and 5-fold better sensitivity than the current qRT-PCR and ELISA
methods. Specific Aim 2: Testing of single SARS-CoV-2 virus and associated IgG/IgM in biofluids from
COVID-19 patients. Milestones. (i) Quantitative analysis of clinical samples with >95% repeatability; (ii) 95%
of concordance for the detection of SARS-CoV-2 between the biochip technology and the lab-based qRT-PCR
and ELISA. Specific Aim 3: Biochip technology transition plan. Milestones. (i) Submission of documentation
to the FDA Center for Devices and Radiological Health (CDRH) for EUA; (ii) Scale-up commercialization plan for
GMP chip production.

Public health relevance
PROJECT NARRATIVE In this project, we propose to repurpose our single exosome-based characterization technology towards the detection of severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2) infection from biofluids. Our approach will enable the simultaneous detection of viral signals and host antibodies, including viral RNA, S- protein, and associated IgG/IgM from the same sample on a single device, thus enabling enhanced diagnosis, disease status, and prognostic assessment of COVID-19.